Neurotropism in a naturally occurring enterovirus infection

PROJECT SUMMARY
Understanding how viruses circumvent immune defense mechanisms to travel throughout the body is of critical
importance to human well-being. The near-eradication of polio, an enteric neurotropic RNA virus that targets
the brain causing paralysis, remains one of our most historic victories in the struggle against human
pathogens. Recent outbreaks of non-polio enteroviruses that also exhibit neurotropism pose potential threats
to public health. However, our understanding of these viruses and their interactions with hosts is still not
complete. The zebrafish model system provides a powerful platform for elucidating host immunity and virus
virulence mechanisms, given the ease of molecular imaging and the abundance of genetic tools. Our recent
discovery of a naturally occurring zebrafish enterovirus (ZfPV) that can easily be transmitted in the lab,
provides an unprecedented tool to study enterovirus infection in a living organism, where the complexity of
natural host-pathogen co-evolution is represented and the model organism is amenable to genetic
manipulation and whole body fluorescence imaging. This novel finding, combined with the fortuitous discovery
that an isogenic zebrafish line, CG2, displays neural infection tropism, provides a unique opportunity to study
enterovirus infection tropism. By investigating natural differences in viral neurotropism observed between two
zebrafish lines, Tübingen and CG2, I will pursue a new understanding of the cellular and molecular processes
underlying viral dissemination from enteric tissue to the nervous system and associated host responses.
Specifically, I will (1) identify genetic loci associated with enterovirus neurotropic susceptibility, (2) identify, at
the single-cell level, which cell populations are infected and the specific cytokine and innate immune signaling
triggered in local and distant tissues, and (3) investigate, in real-time and in a whole organism, the timing of
innate IFN activation and termination, the source, timing, and activity of recruited neutrophils, and the
inflammatory consequences on the local intestinal cell survival. These studies, based on a natural infection
model, will advance our understanding of fundamental mechanisms of viral disease development and uncover
important features underlying the evolution of viral tropism.

Public health relevance
PROJECT NARRATIVE Spread of a viral infection from the intestine to the brain can have a deadly impact on patients. This project will discover the cellular and molecular mechanisms of enterovirus trafficking between tissues in the zebrafish by combining genetic, cellular and live imaging methods. Our study will lead to a deeper understanding of host- virus interactions in living organisms.